Uncovering the function of emerin and its regulation by secretory trafficking in human cardiomyocytes

Project Abstract / Summary
Emerin (EMD) gene mutations cause Emery Dreifuss Muscular Dystrophy type I (EDMD1), a disease
characterized by skeletal muscle wasting and life-threatening atrial defects. However, the mechanism of emerin
dysfunction in the heart is unknown. In this proposal, I seek to understand emerin's role in human atrial cells.
Emerin is a protein of the inner nuclear membrane (INM), and a component of a nuclear cytoskeletal structure
known as the nuclear lamina. Investigators have thus assumed that EDMD1 arises from defects in emerin's
nuclear functions. However, Emerin has been observed at two locations in cardiomyocytes (CMs); emerin also
localizes to the cardiomyocyte intercalated disc (ID)—a specialized plasma membrane (PM) domain that
electromechanically couples cardiomyocytes to one another. Both of emerin's observed locations are essential
for CM gene regulation and biomechanics, though we do not understand emerin's role at either structure. Our
understanding has been limited by 1) the lack of tools to manipulate emerin's distribution, and 2) the lack of
models to study these CM-specific mechanisms. This proposal will overcome these roadblocks by manipulating
emerin's localization in human induced pluripotent stem cell-derived atrial cardiomyocytes (hiPSC-ACMs).
Until our recent discovery, we did not know how emerin localizes to the PM, which impeded our ability to test its
functions there. However, we have discovered that emerin can traverse the secretory pathway through vesicular
transport to the plasma membrane. We hypothesize that secretory trafficking routes emerin to the ID to perform
a specific function in cardiomyocytes. To test this hypothesis, I will first engineer a model cell system to assay
emerin dynamics. Emd -/- mice do not display EDMD1 phenotypes and are thus a poor model of emerin
pathology. hiPSC-ACMs, however, are tractable, mutable, and applicable to human disease. I have previously
identified motifs within emerin that control its trafficking. Using this knowledge, I will introduce a panel of mutants
with enhanced or blocked trafficking into emerin knockout hiPSCs. Using the cell lines I generate, I will test how
emerin disruption affects ACM gene regulatory networks (Aim 2) and cellular mechanics (Aim 3). By controlling
emerin's secretory trafficking, I will also test how its localization at the PM or INM influences these functions.
This system will illuminate emerin's fundamental roles in human atrial cardiomyocytes for the first time. By
defining these mechanisms, we will better understand EDMD1 cardiac defects and open the door to new
potential therapies.

Public health relevance
Project Narrative Emery-Dreifuss muscular dystrophy type 1 (EDMD1) is a hereditary muscular dystrophy that causes profound atrial arrhythmia. EDMD1 is caused by loss-of- function mutations to the nuclear membrane protein emerin, but how emerin influences atrial cell health remains a mystery. We propose a new model system to study this disease, and will use this system to define how emerin is regulated by dynamic trafficking through the secretory pathway in human atrial cells.